Unlocking BIN1 function in oligodendrocytes and support of axon integrity

Project Summary
Myelin is essential to rapid axonal impulse propagation and long-term integrity and survival of axons. Cerebral
white matter alterations are common early features in late-onset Alzheimer’s disease (AD) brains, yet the
cellular basis for these changes, long before the formation of senile plaques and Tau-containing neurofibrillary
tangles, remains largely unexplored. Large unbiased transcriptome studies recently revealed alterations in
myelination and axonal integrity at the early stage of Alzheimer’s disease, suggesting potential contributions of
myelin-producing oligodendrocytes to AD pathogenesis. Interestingly, the second most prevalent genetic risk
factor for late-onset Alzheimer’s disease, BIN1, is highly expressed by mature oligodendrocytes. However, little
is known about BIN1 functions in oligodendrocytes under physiological or pathophysiological conditions. Our
preliminary data suggest that BIN1 protein is distributed at discrete locations in the cytoplasmic channels of
uncompact myelin regions. Moreover, specific deletion of Bin1 in mature oligodendrocytes in adult brain results
in age-dependent disruption of axon integrity and degeneration in the absence of overt demyelination. Because
oligodendrocyte uses cytoplasmic channels to connect soma to distant peripheral processes that enwrap and
interact with the axon, and because BIN1 plays a critical role in vesicle dynamics and membrane remodeling,
we hypothesize that BIN1 functions in oligodendrocyte/axon communication and that loss or dysfunction of the
oligodendrocyte-BIN1 axis aggravates age-associated myelin/axon deterioration and Tau pathology. In this
research proposal, we will use oligodendrocyte-specific BIN1 conditional knockout mice to investigate the
functional role of oligodendrocyte-BIN1 in myelin/axonal integrity in normal aging and in a Tauopathy mouse
model of AD. Understanding BIN1-associated physiological and pathophysiological pathways will likely provide
new insights into how this risk factor might relate to the onset and/or progression of late-onset Alzheimer’s
disease and related dementias.

Public health relevance
Project Narrative BIN1, the second most prevalent genetic risk factor for late-onset Alzheimer's disease (AD) and related dementias, is recently found primarily localized to myelin sheath producing cells - oligodendrocytes. As myelin is critical to axonal impulse conduction and maintenance of axonal integrity and long-term survival, aberrations of oligodendrocyte-axon interactions could exacerbate AD-associated axonal pathology. This study will use genetically engineered mice where BIN1 is selectively altered in oligodendrocytes to investigate BIN1's function under normal aging and Tau-related pathological conditions, which will likely uncover potential pathogenic mechanisms for this common risk factor.